Georgia NCI Community Oncology Research Program (GA NCORP)

The Georgia Community Oncology Research Program (Community Site) represents the collaboration between two NCCCP community hospital-based cancer programs, Northside Hospital Cancer Institute in Atlanta, GA, and the Lewis Cancer & Research Pavilion in Savannah, GA, with investigators from a statewide research network of community hospital based and private practice oncologists through the Georgia Center for Oncology Research and Education (Georgia CORE). The proposed Community Site consortium provides care to approximately 23,000 newly diagnosed patients with cancer in Georgia and has enrolled over 3,300 patients to NCI-sponsored trials since 2014.
Through an integrated organizational and leadership structure, leading cancer researchers in the components and partner research sites are poised to build on a 30-year history of collaboration to further enhance the quality of cancer care through improved access and enrollment to NCI-sponsored trials to address the goals of the NCORP. Four specific aims are implemented to achieve the overall goal of GA NCORP: 1) to increase the number of eligible patients at risk for, or diagnosed with, cancer and who are provided access to, and enroll in, cancer clinical trials within their community; 2) to enroll participants from all populations across all study types and settings to reduce cancer; 3) to create a balanced trial portfolio between treatment trials and cancer control and prevention trials; and 4) to increase accrual and expand network-wide participation in cancer care delivery research. Achieving these aims will improve the quality of care in Georgia through increasing cancer research in local communities, identifying best practices for research accruals, and maximizing capacity and expertise for cancer research statewide.

Public health relevance
GA NCORP Community Site addresses important challenges in US public health. Advances in clinical care and scientific discovery are not currently available to all groups. GA NCORP will continue to analyze data to identify areas for potential improvement, identify proven best practices, and utilize the expertise of research network affiliates to develop and enhance efforts to achieve access to clinical trials.